Training Program in Emotion Research

This application seeks five additional years of support for the training grant on emotion research at the
University of Wisconsin-Madison. This training program continues to focus on four specific themes: 1.
Personality, temperament, and individual and cultural differences: Lifespan developmental, genetic,
cognitive and biological approaches, and human-computer interaction; 2. Affective neuroscience; 3.
Emotion, health, and wellbeing; and 4. Emotion and psychopathology. In this renewal, funds are requested
for 4 pre-doctoral and 3 post-doctoral stipends/year, the same as our current funding. At the time of the last
competing continuation, this training grant provided support for 5 pre-doctoral and 3 post-doctoral
stipends/year.
Since the time of the last competitive renewal, several additional faculty with research interests centrally in
emotion have been added; the brain imaging facility has been strengthened—the Waisman Center
Laboratory for Brain Imaging and Behavior—that is focused principally on affective neuroscience; the
innovative Center for Healthy Minds, which focuses on contemplative neuroscience and its impact on
positive affect, has continued to expand; and several major collaborative projects focused on emotion in
aging, various areas of affective neuroscience, and affective development have begun. There are now 19
program faculty, drawn from nine academic units, with Psychology as the lead department.
Pre-doctoral trainees will be supported for two years and post-doctoral trainees will be offered up to three
years of support but will be encouraged to write their own post-doctoral training proposals during their initial
year in the program to help leverage the funds we request from this T32.
Major elements of the training program include: a new 15-week Seminar in Emotion course coordinated by
Pollak and held in Fall of odd-number years, providing an overview of the range of thinking, methods, and
approaches to the study of emotion reflected among the T32 Emotion Research Training Grant faculty,
focusing primarily on the four themes upon which the program is based; a Spring seminar each year
associated with the Wisconsin Symposium on Emotion, an annual event at the University of Wisconsin-
Madison that brings 5-6 outside speakers to campus for a meeting on a specific topic in emotion research;
participation in a seminar series devoted to ethical issues in research; and participation in monthly emotion
groups held on a video-conferencing platform each month. We believe this program is unique and provides
an extraordinary opportunity for interdisciplinary training in emotion research.

Public health relevance
This program provides a unique interdisciplinary training opportunity for scientists interested in the study of emotion and its relation to mental health and mental illness. Virtually every psychiatric disorder, and many physical disorders, involves a disorder of emotion and we seek to train the next generation of scientists who can make fundamental discoveries in this area and with this new knowledge, develop new empirically validated treatments. Understanding how emotion contributes to these disorders, the mechanisms by which the relevant brain circuits impact peripheral biology and organ systems, will be essential in the development of treatments that include the mind, brain and body and that are essential for optimal health.